NYR-Diabetes Research Center (NYR-DRC)

ABSTRACT
The Animal Physiology Core (APC) employs sophisticated research methodologies to assist New York
Regional Diabetes Research Center (NYR-DRC) investigators in the in vivo assessment of glucose and fatty
acid metabolism, insulin sensitivity and energy homeostasis in mice and rats. A substantial number of NYR-
DRC members continue to depend upon APC services and scientific input. Since the last grant submission, the
Core has provided 8,380 services to 47 NYR-DRC investigators (27 from Einstein, 9 from Mount Sinai and 11
from affiliated institutions) as well as 6 additional outside non-NYR-DRC investigators. Results from these Core
services have contributed to 40 successful NIH diabetes-related grant applications and 26 from Einstein, 7
from Mount Sinai, (whose direct costs total ~ $10 M/annum) and 7 from non-NYR-DRC sites; 28 are supported
by NIDDK), and 132 peer-reviewed publications from NYR-DRC faculty laboratories. Through collaborative
efforts with the other NYR-DRC Cores, the APC enables investigators to thoroughly characterize the effects of
defined pharmacologic, dietary, environmental and genetic alterations on glucose and lipid homeostasis,
insulin action,and metabolism. To accomplish these goals, the Animal Physiology Core will: 1. Offer advice and
instruction to students, postdoctoral fellows, investigators and technical staff in the design, performance, and
analysis of physiologic approaches and techniques necessary to evaluate the control of glucose and lipid
homeostasis and insulin action in rodents; 2. Make available to investigators specialized measurements of
whole body and tissue-specific glucose metabolism and insulin action in rodent models including insulin,
pancreatic and hyperglycemic clamps and spontaneous glucose monitoring; 3. Provide specialized
gastrointestinal, neurosurgical and histological models for the study of insulin sensitivity, energy balance, and
glucose and fatty acid metabolism; 4. Provide analysis of whole body carbohydrate/fatty acid oxidation, energy
expenditure, thermogenesis, food intake, and locomotor activity using specialized metabolic (indirect
calorimetry) rodent cages; 5. Provide assessment of the effects of diet, exercise, light/dark cycle and
environmental temperature on glucose homeostasis, metabolism, and shivering via electromyography; 6.
Make available to investigators specialized measurements of rodent adipose tissue distribution using magnetic
resonance spectroscopy and microCT. 7; Facilitate and integrate the functional assessments provided by the
APC with assays provided by other NYR-DRC Biomedical Cores. All these services are available to
investigators new to diabetes research, as well as to investigators working on diabetes- related projects that can
be enriched and extended by the use of the expertise and facilities of this Core.

Public health relevance
Relevance The Animal Physiology Core provides a cost-effective and high-quality resources that facilitate the scientific progress made by a large group of scientists committed to improving our understanding of the integrative physiology of diabetes in order to improve the treatment of patients with diabetes.